A genetic approach to elucidate the role of NMDA in the development and function of horizontal connections in ferret visual cortex

Project Summary
The goal of this exploratory proposal is to deliver and express genetic material in the ferret model system early
in development. Our strategy is based on an existing method developed in mouse for the rapid and spatially
localized expression of DNA plasmids in postmitotic cells, a technique termed ‘iontoporation’. We aim to
express CRISPR/Cas9 into ferret primary visual cortex (V1) to manipulate the expression of specific genes
critical for the development and function of visual circuitry. Ferret is an ideal model system, as they are born
relatively immature and visual circuit development is well-characterized. In this application, we propose to
optimize and validate iontoporation in ferret to knockdown the expression of N-Methyl-D-aspartic acid
receptors (NMDARs) to elucidate their functional role in the formation and function of V1 circuitry. We will
validate the technique in vitro and in vivo, and start obtaining preliminary data for a collaborative R01, on the
role of NMDARs in the development and function of local and long-range (between columns) horizontal
connections in layers 2-3 of ferret V1. Successful development of this approach will open the door to genetic
manipulation in a higher mammal with cortical columnar organization of the neocortex similar to primates and
humans. It will also allow the development of genetic models of brain pathologies such as Schizophrenia.

Public health relevance
Project Narrative Genetic manipulation in non-genetically tractable, higher mammals, is a critical step towards causally testing hypotheses of sensory information processing and brain development as well as generating disease models that mimic human conditions such as schizophrenia. We will develop and validate a method for rapid and precise delivery of plasmid DNA in ferret primary visual cortex.